Establishing the anatomical and functional mechanisms of white matter deep brain stimulation

Project Summary
Deep brain stimulation (DBS) targeting white matter instead of specific nuclei or cortex is an emerging therapeutic
approach for individuals with treatment resistant neurological or psychiatric disorders. This treatment approach
is thought to have its beneficial effects through functional modulation of neural activity across distributed brain
networks that connect through the white matter that is being stimulated. Evidence for this is, however, in short
supply. This means that the underlying functional and anatomical mechanisms that contribute to the therapeutic
effects of white matter DBS are poorly understood. Lack of this knowledge hinders refinement of this treatment
and its potential use to target other white matter tracts. Here we will model the effects of DBS in macaques and
determine the mechanisms engaged by DBS therapy that targets the location where three white matter tracts –
forceps minor, uncinate fascicle and cingulum bundle – overlap in frontal cortex adjacent to subcallosal anterior
cingulate cortex (ACC). We will employ this model as prior work has shown that stimulation of these tracts is
associated with both fast positive changes in affect as well as slower longer-term effects on affective state that
develop over many weeks in people with treatment resistant mood disorders. Our aim here is to establish the
micro- and meso-scale neurological changes across both time frames caused by deep brain stimulation. We
hypothesize that they are caused by two distinct mechanisms. The fast effects are the result of functional
changes whereas the slow changes are the result of structural changes to white matter. To test our hypothesis,
we will use a combination of deep brain stimulation, resting-state fMRI, neurophysiology, and postmortem
anatomy in macaque monkeys. Using the same diffusion imaging tractography approach used in human patients,
mini-deep brain stimulation electrodes will be targeted to the confluence of three white matter tracts. We will then
assess the progressive systems level changes in fMRI resting-state functional connectivity and diffusion
weighted imaging estimates of anatomical connections that are caused by deep brain stimulation of these three
white matter tracts. In parallel, we will assess the microscale neurophysiological changes that occur as a result
of stimulation. Here our experiments are designed to discern the immediate effects of stimulation on functional
interaction between areas that directly connect through the white matter adjacent to subcallosal ACC as well as
the longer-term changes in functional communication between areas. Finally, we will characterize the changes
in anatomy that are associated with the brain-wide functional effects of deep brain stimulation to white matter.
Here we will use both confocal and electron microscopy to discern alterations to white matter that are caused by
stimulation. Completing these experiments will begin to reveal the functional and anatomical mechanisms of
DBS when it is directed to white matter. Overall, what we discover will provide insights into how circuit-level
functions are modulated by DBS as well as aid the refinement of emerging DBS treatments.

Public health relevance
Project Narrative White matter deep brain stimulation is a rapidly developing therapy for individuals with treatment resistant neurological and psychiatric disorders. Despite this, little is known about the specific anatomical and functional mechanisms that are engaged when stimulation is applied in this way. Here we will address these issues using a combination of resting-state fMRI, diffusion tractography, multi-site neurophysiology, and postmortem anatomical analysis in macaques.